The Role of Yes Associated Protein (YAP) in Hypertrophic Cardiomyopathy

Project Summary/Abstract
Hypertrophy Cardiomyopathy (HCM) is the most prevalent hereditary cardiovascular disease – affecting 1 in
500 individuals. Advanced forms of the disease clinically present with hypercontractility, hypertrophy
(enlargement of the organ and individual cardiomyocytes) and fibrosis. Several single-point mutations in b-
myosin heavy chain (MYH7), Myosin Binding Protein C (MYBPC3), and Troponin (cTn) have been associated
with HCM and increased contractility at the organ level. However, the kinetics at the molecular level remain
unclear, as different sarcomeric protein mutations can result in increased, decreased, or unchanged force
production. A knowledge gap persist in understanding how these altered kinetics at the molecular level lead to
the more advanced hypertrophic phenotype of HCM at the cellular level. Interestingly, the Hippo Pathway has
been demonstrated to be activated during developmental growth, quiescent during cardiac homeostasis, and
reactivated in pathological growth (i.e. HCM). However its involvement in the disease, in particular the initiation
of the hypertrophic phenotype, is poorly understood. Here, we aim to understand whether homeostatic
mechanical signaling through the canonical growth regulator, Hippo-YAP, is altered 1) by changes in the
biomechanics of single HCM mutant cardiomyocytes and 2) by alterations in the mechanical environment. We
propose to use human induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CMs) genetically edited to
harbor point mutations associated with HCM, as a reduce ordered model to study the relationship between
mechanical signaling and hypertrophic growth. We will modulate mechanical stresses (i.e. diseased conditions)
in healthy and diseased cardiomyocytes by treatment with inotropic drugs and culture in fibrotic-like stiff
conditions and track the resulting signaling events by fluorescently labeling the key regulatory protein of the
Hippo pathway (YAP). To further elucidate the mechanism by which YAP is contributing to the phenotypes of
HCM we have developed a novel optogenetic tool, termed OptoYAP, which provides full temporal and spatial
control of the Hippo pathway. Lastly we aim to understand the mechanism behind the reactivation of YAP in
pathological conditions by perturbing the mechanical signaling by the nucleus. We hypothesize that 1) changes
in force production alter the homeostatic mechano-signaling of the Hippo pathway to initiate cellular
hypertrophy and 2) subsequent changes to the extracellular environment (stiffening) compounds this effect
leading to a feedforward signal progressing the disease phenotypes. 3) pathological YAP signaling is driven by
excessive force transmission by the cytoskeleton resulting in nuclear deformation. Our results will provide
insights into HCM progression and provide a testbed for therapeutic options in treating HCM.

Public health relevance
Project Narrative This research training plan will address the knowledge gaps in the development and progression of the most common inherited cardiac disease, Hypertrophy Cardiomyopathy (HCM). Several single point mutations in b- myosin heavy chain (MYH7), myosin-binding protein C (MYBPC3) and cardiac troponin (cTn) have been associated with HCM and increased contractility at the organ level; however, the kinetics at the molecular level remain unclear, as different mutations can result in increased, decreased, or unchanged myosin force production. This research will focus on changes in biochemical signaling of HCM mutant cardiomyocytes, specifically through the Hippo pathway, which is known to be a homeostatic regulator of cellular size, a hallmark of HCM.